Engineering microcapsules for scalable differentiation of human pluripotent stem cells into hepatocytes

ABSTRACT
Millions of people worldwide are affected by liver diseases. Some of these individuals progress to acute or acute-
on-chronic liver failure where liver transplant becomes the only recourse. Given the shortage of transplantable
organs, over >40% of patients on the waitlist do not receive a liver transplant in a timely manner. This motivates
a strong interest in developing bioartificial liver (BAL) systems that may be used as a bridge-to-transplantation
or a bridge-to-recovery for patients with liver failure. BAL systems are populated with liver cells (hepatocytes)
that perform a wide array of liver functions (e.g. protein synthesis and glucose regulation) in addition to detoxifi-
cation. Ideally, BAL systems should contain human hepatocytes, however, because such cells are typically
derived from cadaveric organs, their availability is limited. Use of xenogenic (e.g. porcine) hepatocytes is com-
mon but less than ideal because of the potential for zoonotic transmission of diseases. Human embryonic stem
cells (hESCs) and induced pluripotent stem cells (iPSCs), generally known as human pluripotent stem cells
(hPSCs), may be expanded indefinitely and differentiated into any desired cell type, including hepatocytes.
hPSCs hold incredible promise as the source of cells for many therapeutic strategies, including BAL systems.
There are, however, distinct challenges that remain to be addressed: 1) stem cell (SC)-hepatocytes need to be
differentiated at scale to achieve sufficient liver mass (~ 200 gr) to treat a patient, and 2) functionality of SC-
hepatocytes needs to be improved to approach that of adult hepatocytes. Our project will take a step toward
addressing these challenges by developing bioactive heparin-containing microcapsules that will carry hPSCs,
will be loaded with growth factors for local and sustained delivery, and will enable high-density suspension cul-
tures.
Broader Impact: This project will enable scalable differentiation of hPSCs through the use of microencapsula-
tion. Microcapsules will be used to deliver inductive cues for stem cell differentiation and will protect cells from
mechanical damage in a stirred bioreactor. The use of microcapsules will allow us to increase the rate of oxygen
and nutrient delivery to the cells and will enable higher density cultures. While the present project focuses on
using encapsulated SC-hepatocytes in a BAL system, immunoisolation and other survival advantages offered
by microcapsules will also enable future applications for cell transplantation.

Public health relevance
NARRATIVE Stem cell-based therapies offer tremendous promise for curing a number of human diseases, however, there is a need to decrease cost and improve efficiency of stem cell differentiation. Our project addresses this need through the development of novel cell carriers that allow to decrease the use of expensive reagents and to cul- ture stem cells more scalably.